Double strand break repair maelstrom: causes, mechanisms and genome destabilizing consequences

Maintaining genetic stability is of paramount importance for the survival of cells and organisms. Double-strand
DNA breaks (DSBs) are the most lethal DNA lesion threatening genomic stability, and cells have evolved a
variety of mechanisms for their repair. While some of the repair mechanisms are accurate, others are “risky”
and can further destabilize the genome, leading to cancer and other diseases in humans. The molecular
events that draw the intermediates of otherwise accurate repair pathways into a “maelstrom” of destabilizing
DNA repair mechanisms, where these intermediates are then processed through risky DNA repair pathways,
remain unexplored. The goal of our research is to understand how DSB repair is channeled into the deleterious
repair pathways, with particular emphasis on three DSB repair phenomena: 1) break-induced replication (BIR),
an unusual type of long-tract repair DNA synthesis that promotes bursts of genetic instabilities; 2)
microhomology-mediated BIR (MMBIR), a replicative pathway involving multiple template switching events at
positions of microhomologies that yields complex genomic rearrangements; and 3) the transformation of long
single-strand DNA intermediates of DSB repair into “toxic” joint molecules promoting cell death. As a starting
point, we are using our dependable and powerful system in yeast, where a single DSB is initiated by a site-
specific HO endonuclease; we have demonstrated that all three of the repair events of interest can be used to
repair the lesion in this system. The knowledge obtained using this system – the repair mechanisms,
intermediates, participating proteins, and mutation patterns – is used to inform the experimental design of
studies that will evaluate these pathways in other yeast and mammalian systems. Conceptually, the long-term
goals are the same across projects and involve three primary areas of inquiry. First, using sensitive genetic
approaches, proteins and DNA motifs whose presence affect the funneling of the repair intermediates into the
“maelstrom” of destabilizing repair mechanisms will be identified. Second, a combination of in vivo and in vitro
approaches will be used to model and investigate the cell's decision points to understand the circumstances
(structures, kinetics, participating proteins, etc.) that draw intermediates into high-risk and/or toxic repair
pathways. Third, the patterns of mutations and chromosomal rearrangements that result from the deleterious
repair pathways will be evaluated, and computational approaches will be used to apply these findings to
human genome databases. To this end, MMBIRFinder, new software developed from previous research, will
be used to detect complex genetic changes that cannot be found by currently available algorithms. Overall, this
research program will bring improved clarity regarding the mechanisms of DNA repair intermediate processing,
which will uncover factors that influence the regulation of dangerous repair pathways and result in
destabilization of the genome in eukaryotes.

Public health relevance
The relevance of complex genetic changes to many human diseases, including cancer and many neurological and developmental syndromes, is well established. Emerging evidence increasingly underscores a critical role for mis-channeled DNA repair events, where alternative, deleterious repair pathways are used, in generating these genome rearrangements. The proposed work will unravel the molecular events driving repair of DNA breaks into a maelstrom of destabilizing mechanisms that result in disease-promoting genomic changes, and it will identify potential points of therapeutic intervention for diseases rooted in genome instability.